Clinical Trials Network: Pacific Northwest Node

PROJECT SUMMARY/ABSTRACT
Changes in the healthcare delivery system brought about nationally by the Affordable Care Act and the Mental
Health Parity and Addiction Equity Act have expanded substance use disorder (SUD) treatment beyond
specialty care, and integrated it into primary care and acute care medical settings where SUD prevalence rates
are high. There is an increased need for future research to develop and test the effectiveness of SUD
interventions implemented in healthcare settings and linked to specialty SUD treatment programs. The NIDA
National Drug Abuse Treatment Clinical Trials Network (CTN) has prioritized this need, as it faces an opioid
epidemic, resurgence of methamphetamine, and co-occurring substance use and mental health and physical
disorders. In order to contribute to the CTN's expanded objectives and research priorities, the Pacific
Northwest (PNW) Node proposes the following Specific Aims: (1) Increase the capacity of the PNW Node
research team by adding investigators with demonstrated practical and research expertise addressing opioid
use dependence, other substances of abuse, co-use of substances, implementation of novel behavioral and
pharmacological treatments, primary care practice-based research networks, collaborative care models,
integration of behavioral health and SUD treatment components into primary and acute care settings, and
harmonizing electronic medical record systems across multiple health care systems; (2) Expand the scope,
population, diversity, and focus of the PNW Node’s roster of research, clinical practice, and dissemination
settings by including a number of large state-wide and regional practice-based primary care clinical and
research networks involved in integrated behavioral health collaborative care; (3) Design and conduct
pragmatic, comparative effectiveness, registry, and other types of innovative studies, informed bidirectionally
by SUD researchers, clinicians, primary and acute care providers, and enhanced by use of electronic health
records (EHRs), that implement and evaluate integrated behavioral and pharmacological treatments for illicit-
and misused prescription opioids, methamphetamine, and alcohol; (4) Provide information dissemination,
training and technical assistance to affiliated health care and SUD providers, researchers, and the public about
opioid use disorders, other SUDs, collaborative care and chronic disease management models, the integration
process, and linkage between primary care and specialty SUD programs through the CTN National
Dissemination Library, the Northwest Addiction Technology Transfer Center, the UW Alcohol and Drug Abuse
Institute, the WSU Rural Mental Health and Substance Abuse Center of Excellence, and the Center for Rural
Opioid Prevention, Treatment, and Recovery.

Public health relevance
PROJECT NARRATIVE Many individuals with substance use disorders (SUDs) do not seek treatment in specialty SUD treatment programs, particularly those in rural settings and those with co-occurring medical and mental health conditions. The integration of SUD treatment into healthcare settings under the ACA-driven healthcare reform requires research to identify, engage, and treat individuals with SUDs more effectively within primary and acute care settings, using electronic medical records to identify individuals at risk and utilizing novel treatment and technology approaches to address their substance use disorders